NEUROPSYCHOLOGY SUBJECT MATTER EXPERT IN THE TRANSLATION, CULTURAL VALIDATION, AND NORMATIVE TESTING FOR THREE NEUROCOGNITIVE TOOLS USED IN NCI CLINICAL TRIALS.

DCP REQUIRES AN ACADEMIC EXPERT IN NEUROPSYCHOLOGY: SUBJECT MATTER EXPERT IN THE TRANSLATION, CULTURAL VALIDATION, AND NORMATIVE TESTING FOR THREE NEUROCOGNITIVE TOOLS USED IN NCI CLINICAL TRIALS.